High resolution approaches to defining organelle heterogeneity in Trypanosoma brucei

ABSTRACT
Glycosomes are specialized peroxisomes of kinetoplastids that harbor multiple biochemical pathways.
Highlighting the importance of these organelles, disruption of glycosome integrity is lethal. Despite their essential
nature, our understanding of the processes involved in maintaining glycosome homeostasis is limited. For
example, we do not know the extent to which different metabolic pathways are localized together within a single
glycosome or are instead separated into distinct glycosome populations. Additionally, we do not know how these
organelles are formed. In large part, this gap in knowledge is due to a lack of experimental tools available for
studying organelle biology. Glycosomes are heterogeneous and we hypothesize that this heterogeneity reflects
both functional specialization (the localization of metabolic enzymes to different glycosome populations) and
vesicular intermediates formed during glycosome biogenesis. Biochemical fractionations and widefield
fluorescence imaging show that metabolic enzymes and proteins involved in glycosome/peroxisome biogenesis
called peroxins (Pexs) exhibit distinct localization patterns. These studies suggest that glycosomes differ in their
functional capabilities as well as their maturation status. However, the limitations of these approaches prevent
us from assigning a protein to a specific glycosome. In Aim 1, we will use superresolution imaging techniques to
quantitate the extent to which the glycosome proteins that exhibit distinct localization patterns localize to different
glycosomes. Subcellular organelles from Trypanosoma brucei are difficult to resolve biochemically and
significant cross-contamination occurs with current approaches. In Aim 2, we will develop methods to use
fluorescence activated organelle sorting (FAOS), a novel and powerful method, to purify and characterize
subcellular organelles including glycosomes. This work will dramatically advance our understanding of parasite
cell biology in several ways. It will enable the efficient, rapid isolation of organelles of higher purity than current
approaches, the separation of organelles based on their internal composition, and analysis of single organelles,
which will be useful in future studies of glycosome heterogeneity. The methods defined herein can be used to
purify organelles from other eukaryotic cells and can be expanded to include functional dyes or fluorescent
biosensors to follow metabolic function. The definitive finding that glycosomes are functionally specialized will
provide insight into metabolism and establish a foothold into defining the targeting sequences and organelle
receptors involved in establishing and maintaining this compartmentalization. The demonstration that glycosome
heterogeneity represents intermediates in the biogenesis pathway would lay the groundwork for resolving
different glycosome biogenesis pathways and the role they play in parasite biology. This work will forward our
understanding of glycosome biology as well as develop experimental approaches that can be applied to
organelle studies in other eukaryotes.

Public health relevance
NARRATIVE Kinetoplastid parasites cause diseases that affect more than 20 million people worldwide and the drugs currently used in the treatment of these diseases are toxic and difficult to administer. Glycosomes are kinetoplastid specific organelles that are essential for parasite survival. The proposed work aims to resolve the molecular mechanisms that regulate glycosome biogenesis for the purpose of exploiting them for drug development and to train young scientists in the approaches necessary to study these processes.